Health Opportunities & Promoters of Equitable Screening for Lung Cancer (Hopes for Lung Cancer)

PROJECT SUMMARY
Candidate: This resubmission for the NCI K08 Mentored Clinical Scientist Research Career
Development Award to Promote Diversity describes Efrén J. Flores, MD as a candidate who is well-
positioned to successfully complete the proposed training objectives and research aims. Dr. Flores’
background as a Hispanic physician and clinical researcher has focused on achieving equity in lung
cancer outcomes through early detection by developing novel interventions to increase LCS uptake
among Hispanic and othervulnerable populations. Background: Lung cancer remains the leading
cause of cancer-specific mortality in theUS, and Hispanics experience worse lung cancer outcomes
and die at higher rates due to advanced stage at presentation. Lung cancer screening (LCS) can
save many lives through early lung cancer detection among Hispanic current and former smokers.
Still, without increasing efforts to improve smoking status disclosure and documentation and tailored
interventions to promote LCS uptake among Hispanic current and former smokers, this underserved
population will continue to demonstrate disparities in lung cancer survival. Study aims: Based on prior
research experience, Dr. Flores has adapted the NIMHD research framework by incorporating
elements from Ford’s evidence-based theoretical model to guide the following proposed study aims:
1) To elucidate barriers and facilitators to consistent identification and documentation of smoking
status to promote LCS uptake among Hispanic current and former smokers; 2) To assess feasibility,
acceptability, and reach of the digital delivery of an educational video to promote LCS uptake among
Hispanic current and former smokers; 3) To explore the effect of the digital delivery of the educational
video to increase interest, intent, and scheduling of LCS uptake among Hispanic current and former
smokers. Training: The career development plan will allow Dr. Flores to develop expertise in tailoring
LCS interventions among Hispanic communities by completing training objectives in three areas: 1)
mixed methods to inform health interventions; 2) community-based participatory research to guide
outreach interventions; 3) digital interventions tailored to promote LCS uptake among Hispanic
communities. Advanced coursework, a resource-rich institutional environment, and the proposed
research study will support these training objectives. Mentorship: A team of expert mentors,
including Dr. Elyse R. Park (primary mentor),Dr. Ruth C. Carlos (co-mentor), and Dr. Kelly E Irwin
(co-mentor), and scientific advisors including Dr. Jennifer Haas, Dr. Nancy Rigotti, Dr. Giselle Perez,
Dr. Jo-Anne Shepard, Dr. Joseph Betancourt, and Dr. Nathaniel Mercaldo will guide Dr. Flores’
training and research efforts for the duration of the award. Impact: The successfulcompletion of this
proposed K08 award will provide Dr. Flores with the rigorous training and research expertise that will
provide high-quality data to inform an NCI R01. It will also serve as a foundation for him to become
a leading independent investigator developing novel interventions to overcome disparities and
advance equity in lung cancer outcomes among Hispanics and other vulnerable populations.

Public health relevance
PROJECT NARRATIVE Lung cancer remains the leading cause of cancer-specific mortality in the US, and Hispanics experience worse lung cancer outcomes due to advanced stage at presentation. Lung cancer screening (LCS) can save lives and improve disparities through early detection among Hispanic current and former smokers. Still, without tailored interventions, Hispanics will continue to die from lung cancer at higher rates. This K08 NCI proposal entitled Health Opportunities & Promoters of Equitable Screening for Lung Cancer (HOPES for Lung Cancer) offers an innovative approach to promote LCS uptake among Hispanic current and former smokersby elucidating barriers and facilitators to consistent documentation of smoking status to promote LCS uptake opportunities and leveraging the rise of digital health to assess the reach of the digital delivery of an educational video tailored to promote LCS uptake among Hispanic communities.